Viral Testing Core

Virus Testing Abstract
The CNPRC has maintained a pedigreed colony of Indian origin rhesus macaques for
over 22 years. The SPF Pedigreed Indian origin rhesus colony includes both an SPF
level 1 colony negative for Simian Retrovirus (SRV), Simian Immmunodeficiency Virus
(SIV) and Simian T Cell Lymphotrophic Virus (STLV) Herpes B virus (B virus) and an
SPF level 2 colony free of three additional viruses including include rhesus
cytomegalovirus (RhCMV), simian foamy virus (SFV), and rhesus rhadinovirus (RRV).
SARS-CoV-2 assays will also be added to the routine screening panel. The four
principal goals of this application are:
Continue to expand the SPF Level 2 population relative to Level 1. Include SARS-
CoV-2 surveillance as part of the SPF panel.
Develop improved and expanded screening and confirmatory tests for detection of
SPF agents to facilitate maintenance of the SPF colony. This work includes new
assays for agents such as tuberculosis, which represents the first SPF agent.
Evaluate addition of Mamu-B*17 to the currently tracked MHC alleles, Mamu-A*01,
Mamu-A*08, and Mamu- B*01.
Continue the collection and storage of microbiome and lymphocyte samples in the
unique biorepository of SPF2 to facilitate future research projects investigating the
interaction of HIV with the host microbiome and immune system.
Project Summary/Abstract Page 93